Signal transformations in the vestibulo-ocular circuit

PROJECT SUMMARY
The vestibular system is essential for many functions, including maintaining balance and orchestrating reflexes.
For instance, the vestibulo-ocular reflex (VOR) is necessary for stabilizing eye fixation with head movement.
However, the role that individual cell types play in orchestrating the VOR motor response is not fully determined.
Previous research has been limited by serial single-unit recordings, which cannot capture the dynamics of
simultaneous activity across synapses, and limited behavioral testing sets, which result in confounding co-
variation between predictor variables. Three related questions of VOR function are how vestibular information is
integrated with other input pathways (e.g. visual and efference copy inputs), how neural processing changes
over the course of VOR adaptation (specifically, to gain or phase), and what mechanistic means are used to
create VOR learning. The goal of this proposal is to answer these three questions in mice, using large-scale in
vivo electrophysiology during innovative probe conditions, carefully designed training sets that dissociate learned
timing from learned gain responses, and precise genetic interrogation to conditionally manipulate molecular
signaling at a key point in the VOR circuit. Neural responses will be analyzed with unbiased computational
models, to fully establish signal transformations between circuit nodes. Determining the signal content in the
cerebellum and brainstem vestibulo-ocular neurons will help answer a decades-long debate about the nature of
plasticity during in vivo learning (depression vs potentiation). Resolving the differences in filtering that occur
over adaptation will illuminate learning motifs of the circuit. Assessing the relative contribution of presynaptic
plasticity to VOR learning will better define specific molecular pathways that could be targeted for specific
therapeutic effects. These experiments will be performed in an ideal research setting at Stanford University, with
specially-prepared equipment and access to leading experts in vestibular research and neuroscience more
generally. The overall outcomes of this study will contribute significantly to the goal of defining normal and
disordered processes in vestibular function.

Public health relevance
PROJECT NARRATIVE The vestibular system performs sensorimotor computations that are critical for controlling balance, posture, and awareness of position relative to the world. My goal in this proposal is to test how vestibular signals are combined using distinct, dynamic transformations with other sensory input to accurately control reflexive eye movements. Addressing this problem has major implications for human health because disruptions in normal vestibular motor control underlie serious diseases.